POLYCOMB REPRESSIVE COMLEXE AS KEY REGULATORS OF HIV LATENCY AND TARGETS FOR LATENCY REVERSAL

ABSTRACT: POLYCOMB REPRESSIVE COMPLEXES AS KEY REGULATORS OF HIV LATENCY AND
TARGETS FOR LATENCY REVERSAL
In an effort to achieve a cure for HIV, approaches to eliminate the persistent reservoir of latent HIV infection are
needed. Enforced by a delicate balance of regulators of viral and cellular gene expression, the persistence of
the quiescent retroviral genome is a remarkable way by which the virus ensures its stability within the host.
Manipulation of viral latency to allow renewed viral expression and the potential for viral clearance is a leading
strategy for HIV cure in chronically infected patients. Chemical strategies that promote reversal of viral latency
by disrupting repressive epigenetic processes represent a groundbreaking step towards a clinical strategy to
cure HIV. Fortuitously, the effort to epigenetically reactivate HIV proviruses has intersected with the scientific
community’s interest in chromatin regulation and an increased appreciation for the role of epigenetic chemical
probes in driving biological understanding of their targets. Proof of concept studies in reactivating HIV
transcription via inhibition of epigenetic regulatory proteins have yielded promising results. However, many of
these compounds exhibit only modest latency reversing activity, and only a limited number of chemical tools to
achieve this goal are currently available. A better understanding of the landscape of epigenetic pathways that
influence proviral latency, as well as novel chemical tools, are clearly needed to develop fully effective latency
reversing agents (LRAs) for use alone or in combination towards an HIV cure.
The overarching objectives of this proposal are to apply genetic, biochemical, and chemical biology approaches
to cellular models of latency and HIV+ donor-derived samples to i) define the role of the Polycomb Repressive
Complexes, PRC1 and PRC2, in HIV latency and ii) understand the effect of substance use on Polycomb-
mediated HIV latency. PRC1 and PRC2 are critical regulators of gene silencing through the installation and
recognition of the repressive H3K27me3 post-translational modification (PTM), and hence, are well poised to
make a significant contribution to HIV latency. Our preliminary data suggests that components of both PRC1 and
PRC2 that have not yet been implicated in the maintenance of HIV latency, as well as Polycomb-associated
proteins, are key regulators of latency and novel targets for latency reversal. Additionally, drugs of abuse have
been shown to induce changes in epigenetic modifications, including histone methylation, and in turn could
significantly impact the epigenetic profiles of resting CD4+ T-cells from HIV-infected drug abusers. Therefore,
we also aim to explore the effect of substance abuse on Polycomb function in resting CD4+ T-cells, and the
influence of such environmental factors on the establishment and maintenance of HIV latency.

Public health relevance
PROJECT NARRATIVE An HIV cure is urgently needed due to the financial burdens and compliance issues associated with lifetime therapies, as well as increased risk of adverse effects or immune activation associated with long-term antiretroviral therapy (ART). A widely applicable HIV cure has remained elusive, in part, due to the persistence of a viral reservoir composed of transcriptionally silent provirus integrated within host cellular DNA; therefore, chemical strategies that promote the reversal of viral latency by disrupting repressive epigenetic processes represent a groundbreaking step towards a clinical strategy to cure HIV. By investigating the regulation of proviral quiescence by Polycomb Repressive Complexes in HIV infected patients and the role of drugs of abuse in this process, we will dramatically advance our current understanding of persistent HIV infection and guide the development of novel therapeutic approaches toward an HIV cure.